Core B: Shared Resource Core For Characterizing Antibody Responses To SARS-CoV-2 And Other Pathogenic Human Coronaviruses

Abstract
High-quality recombinant antigens and reliable and accurate SARS-CoV-2 serological assays are urgently
needed for surveillance and for defining the immune mechanisms of viral pathogenesis, viral clearance, and
protection against reinfection. Core B of the UNC SARS-CoV-2 Serological Sciences Center of Excellence will
apply state-of-the-art strategies to establish methods for the production of milligram quantities of homogeneous
recombinant spike protein CoV antigens with versatile tags and site-specific labels and use these antigens to
develop sensitive and reliable singleplex and multiplex Ab detection assays. Core B will interact and support all
the projects driven by the center and collaborators' by providing recombinant antigens and serological assays to
characterize the serum antibody response, elucidate Fc effector functional profiles, and isolate and sequence
antigen-specific immunoglobulin gene repertoire.